MAQFACS: MEASURING FACIAL MOVEMENT IN RHESUS MONKEYS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. This is an ongoing grant to develop an objective coding system for measuring facial movement in rhesus monkeys. It has entered a final year of no cost extension. We are finalizing the test materials, how to distribute this test, exploring intensity ratings and continuing to look for missing movements.